Assessing the effects of peripheral immune activation on the NVU following TBI using avascularized and perfused human blood/BBB model.

PROJECT SUMMARY
Traumatic brain injury (TBI) is one of the leading causes of death and disability worldwide due to its heterogeneity
and complex mechanisms of pathogenesis. Clinical outcomes following TBI are determined by the nature and
severity of the primary injury as well as activation of the peripheral immune response. This project will a) establish
protocols to generate validated human induced pluripotent stem cells (iPSC)-derived brain endothelial cell
(BECs), pericytes (PCs) and astrocytes (ACs) that form a neurovascular unit (NVU), b) develop a novel 3D
perfused blood / blood-brain barrier (BBB) interface model together with patient-derived plasma proteins and
immune cells and c) examine the effects of the blood components circulating in TBI patients on the NVU function.
In preliminary studies and recent publications, we have (i) developed strategies using RNA or viral-induced
transcription factors (TFs) to reprogram somatic cells into iPSCs, (ii) differentiate iPSC-derived epithelial cells
into BECs and validate their identity using multiple approaches, (iii) generate brain organoids that incorporate
blood vessels, (iv) develop brain-on-a-chip models that incorporate blood components and flow. Building upon
these studies, we hypothesize that this multi-disciplinary approach will establish a novel perfused blood-BBB
interface 3D model to evaluate the mechanisms by which blood components (plasma proteins, immune cells)
impair the human NVU after TBI. We will address this hypothesis with three aims. For the R61 phase of the
proposal in Aim 1, we will generate, characterize & validate iPSC-derived mature human NVU-forming cells by
optimizing the published protocols using miRs and BBB-specific TF modulation and verify their molecular identity
and biological function. In Aim 2 (R61 phase), we will establish vascularized and perfused 3D BBB models with
physiological relevant flow rates using a combination of BECs, PCs and ACs, ready-to-use brain-on-a-chip
devises and labelled plasma metabolites and proteins. In parallel we will develop vascularized and perfused
brain organoids with physiological relevant flow and labelled blood components. In these models, we will
characterize BBB function using transcriptomics, cell biological, imaging and functional studies. For the R33
phase of the project (Aim 3), we will analyze the effects of blood components (plasma or immune cells) on: a)
BBB cell biology; b) transport of labelled metabolites, plasma proteins, drugs or immune cells across the BBB;
c) test the effects that blood components have on EC - PC interactions, PC contractility, pericyte or astrocyte
coverage of blood vessels, astrocyte Ca++ signaling; and d) evaluate immune cell trafficking (macrophage, T
cells) and effects of immune cells on the blood/BBB 3D model. The proposed studies will establish an innovative
perfused blood-BBB 3D interface model that will allow us to examine the relationship between blood components
(plasma, immune cells) and the BBB in healthy conditions and brain injury. This model may facilitate discovery
or analysis of potential biomarkers and evaluate the efficacy of potential therapeutics that target the systemic
inflammatory-driven neuropathophysiology in TBI.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is one of the leading causes of death and disability worldwide because the disease is highly heterogeneous with complex mechanisms of pathogenesis and the role of the peripheral immune response on the brain remains unexplored. This project will establish an innovative perfused blood / blood-brain barrier three dimensional interface model that will allow us to examine the relationship between blood components (plasma, immune cells) and the blood-brain barrier in healthy conditions and following TBI. This model may facilitate discovery or analysis of potential biomarkers for TBI and evaluate the efficacy of potential therapeutics that target the systemic inflammatory-driven brain pathophysiology in this disease.